CSHL Single Cell Analysis Course (2023-2027)

ABSTRACT
CSHL Laboratory Course in Single Cell Analysis
The proposed Cold Spring Harbor Laboratory (CSHL) course Single Cell Analysis to be held annually
in July 2023– 2027, is part of the CSHL’s postgraduate training program in cell and molecular biology.
This is a short, intensive 2 week hands-on course which prepares students to enter directly into
research that makes use of advanced and/or specialized molecular techniques in contemporary
aspects of singe cell-based research. General themes to be covered during the course include
quantitative single cell analysis by RNAseq, genomic DNA analysis, proteomics, and metabolomics.
Specific experimental techniques taught in the course include: 1) Droplet- and microwell based single
cell isolation; 2) Single cell RNA seq library preparation; 3) Single molecule FISH; 4) Single cell
peptidomics; 5) Single cell western blot; 6) Photoactivatable single cell probes; 7) Single cell mass
spectrometry; 8) Soft X-ray tomography; 9) Introductory single cell sequencing analysis. Experimental
techniques are taught in the context of the broader conceptual advances that they may provide. The
course invites lecturers who have made significant contributions in their fields to give up-to-the-minute
reports on current research. The trainees are chosen by the course faculty from larger pools of
applicants and range from graduate students to senior investigators and research physicians. Because
of the short duration of this course, senior, as well as junior individuals can attend and receive a short,
intense period of training in an environment remote from other demands on their time and attention.
The course also provides an unusual opportunity for established scientists to apply these advanced
techniques to their own research interests, or to retrain in an important specialty within neuroscience
with which they may not be familiar. Methods and concepts taught in the course are disseminated to
the wider research community through the publication of laboratory manuals and online resources.

Public health relevance
PROJECT NARRATIVE CSHL Laboratory Course in Single Cell Analysis This application seeks funds to support an advanced cell & molecular lab-based short course at Cold Spring Harbor Laboratory, New York. The goal of this two-week course is to teach students cutting-edge wet-lab approaches for single cell analysis, and to provide familiarity with basic bioinformatic approaches to single cell data. Modules of the course will be taught by scientists with expertise in distinct areas of single cell analysis. Trainees include advanced graduate students, postdoctoral researchers and young faculty from throughout the United States and abroad. The selection process for entry into this course is highly competitive, and trainees leave the course armed with new techniques, know-how and potential collaborators to apply to their own areas of research. A significant proportion of trainees subsequently undertake basic or applied research in diseases of child health and/or human development. Methods and concepts taught in the course are disseminated to the wider research community through the publication of laboratory manuals and online resources.